Informant Measures Of Cognitive Decline In Mexico

PROJECT SUMMARY/ABSTRACT
I am an Assistant Professor in the Department of Internal Medicine’s Division of Geriatrics and Palliative Medicine
at the University of Texas Medical Branch at Galveston. My long-term career goal is to become an independent
researcher leading an interdisciplinary team that identifies how family members and informants can be used to
detect early warning signs of mild cognitive impairment and dementia for Mexicans and Mexican Americans. To
accomplish this goal, I will complete three training objectives that build on my prior training in family caregiving for
Mexican American families: (1) clinical use of family members and informants in diagnosis of dementia and mild
cognitive impairment, (2) analysis of surveys and statistical methods for survey validation, and (3) career
advancement and leadership development to gain essential competencies to function effectively as an independent
extramurally-funded investigator, specifically by developing mentoring and leadership skills and enhancing
manuscript and grant writing skills. Training in these areas will include taking coursework, shadowing
interdisciplinary teams in clinical settings, and developing new research areas. My training activities are integrated
with a research project. I will use data from the Mexican Health and Aging Study (MHAS), a nationally
representative longitudinal study of older adults in Mexico, linked with the Auxiliary Study of Cognition (MexCog),
an in-depth study of cognitive functioning of older adults in Mexico, as part of the international Harmonized
Cognitive Assessment Protocol (HCAP) to complete the following specific aims: (Aim 1) describe the informant
assessments in the population and how they vary by dementia status, and evaluate the informant assessments of
cognition to estimate MCI and dementia prevalence, and (Aim 2) examine how adding the informant assessment
improves the performance of the cognitive screening in the questionnaire. The expected findings of this research
will provide evidence of the value of incorporating informant assessments of cognition in population studies to
assess mild cognitive impairment and dementia and more accurately categorize marginal cases. Completion of the
K01 mentored training and research plans will provide me with the knowledge, skills, and expertise required to
understand measurement of cognitive functioning in the specific context of Mexicans to develop a program of
research that blends life course social and health constructs with clinical data, with the goal of incorporating family
members and informants as early warning signs of cognitive impairment and dementia for both Mexican and
Mexican Americans.

Public health relevance
PROJECT NARRATIVE This research project aims to better understand how cognitive abilities, such as memory and problem-solving skills, change as people age in Mexico. The study will use information reported by close family members or caregivers about these cognitive abilities and compare it with clinical assessments. The goal is to improve how we measure and understand changes in cognitive function, which is crucial for planning healthcare services and dementia care.